THE PURPOSE IS TO CONTINUE OPERATION OF THE NIA CTOSC IN ORDER TO PROVIDE SUPPORT FOR THE MANAGEMENT, TRACKING, AND OVERSIGHT OF CLINICAL TRIALS FUNDED BY THE NIA.

THE PURPOSE IS TO CONTINUE OPERATION OF THE NIA CTOSC IN ORDER TO PROVIDE SUPPORT FOR THE MANAGEMENT, TRACKING, AND OVERSIGHT OF CLINICAL TRIALS FUNDED BY THE NIA.